STSS - TASK ORDER 15 - PROGRAM SUPPORT SERVICES 3.0

Shared collaborative cloud environment, including cloud-based productivity tools, a service desk, commercial and open-source deployments of analytical tools for the Rare Diseases Clinical Research Network program (RDCRN). The RDCRN is an initiative of the Division of Rare Diseases Research Innovation (DRDRI), National Center for Advancing Translational Sciences (NCATS). Made up of 20 disease research groups (Consortia) and a Data Management and Coordinating Center that work together improving the availability of rare disease information, treatment, clinical studies, and general awareness for both patients and the medical community.